Society of Toxicology Undergraduate Diversity Program

Project Summary
The Society of Toxicology’s Undergraduate Diversity Program will support travel for about 35
participants, approximately 30 undergraduate students from groups that are under-represented
in the sciences and 5 faculty advisors who have strong potential to encourage students from
these groups to pursue career paths in the biomedical sciences. The number of students from
some demographic groups who are pursuing graduate school in the sciences is far from parity
with their proportion among the US population, and the Society of Toxicology strongly supports
efforts to increase the diversity of the scientific workforce. Selected from a national pool of
applicants, these students and advisors will receive travel support and participate in a 3-day
program March 13-15, 2021, in Orlando, FL, in conjunction with the Society of Toxicology (SOT)
Annual Meeting March 14-18, and at the subsequent meetings in San Diego (2022) and
Nashville (2023). The aims of this program are to 1) increase awareness of undergraduate
students majoring in science and science advisors at undergraduate institutions about career
choices and opportunities in toxicology and 2) increase interest of undergraduate students in
graduate biomedical education and motivate students to obtain research experience especially
that pertinent to toxicology. Participants will hear specially selected presentations by high profile
toxicologists whose work exemplifies diverse research interests, engage in research poster
sessions, and meet with academic program directors and internship sponsors. Students are
grouped into mentoring teams including graduate student peer mentors and toxicologist host-
mentors who provide informal interaction and mentoring during the presentations, scientific and
poster session exploration, and other activities. Potential career choices after the PhD are
examined in roundtable discussions featuring toxicologists who share their experiences in
different employment sectors (academia, government, and industry). The program is based on
the experience from, and evaluation and refinement of, activities across the 31-year history of
the SOT Undergraduate Diversity Program. Other activities supplement this program, including
ToxScholar visits to campuses and support for summer internships. SOT is committed to
activities for increased inclusiveness and diversity in toxicology and the biomedical sciences.

Public health relevance
Project Narrative Toxicology is a discipline and profession that is dedicated to identifying the adverse effects of chemical, physical, and biological agents on living organisms and the ecosystem and to preventing and ameliorating such adverse effects. As a mini conference embedded in the Society of Toxicology (SOT) Annual Meeting, the SOT Undergraduate Diversity Program supports a critical need during the undergraduate years: by immersing students from groups underrepresented in the sciences in a disciplinary science meeting, we encourage them to prepare for and apply to graduate school in the biomedical sciences, thus strengthening the pipeline of future toxicologists. Apart from further developing the talent pool, the SOT meeting and this program benefit public and environmental health by advancing research to protect society and the environment from adverse health risks resulting from exposures to hazardous agents.